EU-US Workshop 'Nucleotide excision repair and crosslink repair - from molecules to mankind'

Title: Nucleotide Excision Repair and Crosslink Repair - From Molecules to Mankind PI: Bennett Van Houten Meeting title: Third EU-US Workshop on Dynamics of DNA repair enzymes involved in nucleotide excision repair and interstrand crosslink repair: from molecules to man? Smolenice Castle, Slovakia, May 11-17, 2017 Abstract: The purpose of this workshop is to bring together scientists from the EU and US to discuss our current understanding of how protein machines assemble and sort through genomic DNA to identify specific damaged sites which are repaired through the two critical repair pathways: nucleotide excision repair or interstrand crosslink repair. Several of the enzymes perform dual functions in both pathways, thus combining these two topics in one meeting provides tremendous synergy and is the unique feature of this workshop. Many endogenous agents, environmental toxicants and chemotherapeutic agents cause DNA damage that is repaired through these two mechanisms. The importance of the repair pathways acting on these forms of damage is underscored by the fact that their loss or dysregulation is associated with a variety of devastating heritable human conditions including cancer, neurodegeneration, premature aging and severe developmental abnormalities. The workshop will move from molecules to man and include a discussion of the disease syndromes associated with poor repair of these damage substrates. The main objective of this workshop is to fully address the problem of damage recognition and processing involved in nucleotide excision repair and interstrand crosslink repair by generating an understanding of the current state of the science and then articulate where the science will go once current technical and scientific hurdles are overcome. The main goals of this workshop are to: 1) highlight the state of the science and current technologies being used to study this problem; 2) exchange ideas between scientists in the EU and US; and 3) provide a forum that allows scientists in the local region an opportunity to meet and engage with scientists from the EU and US who are driving the field.

Public health relevance
Title: Nucleotide Excision Repair and Crosslink Repair - From Molecules to Mankind PI: Bennett Van Houten Meeting title: Third EU-US Workshop on "Dynamics of DNA repair enzymes involved in nucleotide excision repair and interstrand crosslink repair: from molecules to man” Smolenice Castle, Slovakia, May 11-17, 2017 Project Narrative: This innovative meeting is focused on understanding mechanistically how human DNA repair proteins process bulky carcinogenic lesions resulting from environmental insult during nucleotide excision repair and interstrand crosslink repair. Loss of these DNA repair processes results in accumulation of environmental damage to our genetic material causing cancer, neurodegenerative diseases and premature aging.